Advancing Health Information (HIE) During Inter-hospital Transfer (IHT) to Improve Patient Outcomes

ABSTRACT
The transfer of patients between acute care hospitals (inter-hospital transfer, IHT) is often undertaken
to provide patients with specialized care that is unavailable at the transferring hospital. Over 100,000 Medicare
patients with high rates of multiple chronic conditions undergo IHT annually. However, IHT exposes patients to
the risks of discontinuity of care and lacks potential safeguards that might protect against gaps in
communication. Our extensive prior work examining IHT demonstrates sub-optimal transfer processes,
including frequent gaps in communication and inadequate information exchange, with up to 35% of patient
transfers missing essential clinical information on transfer. Sub-optimal HIE during IHT has been associated
with patient harm such as therapeutic errors and delays in care and may contribute to greater mortality
observed among select IHT patients. Given the complexities of this care transition, effective HIE has proven
difficult to achieve due to the need for solutions to address workflow, data visualization and interoperability to
be effective.
The overall goals of this study are to leverage our extensive research experience in IHT and health
information technology innovation to design, implement, and rigorously evaluate an intervention to improve HIE
during IHT in three use cases with different levels of integration between transferring and accepting hospitals:
hospitals within the same health system, hospitals in different systems that share a common EHR, and
hospitals in different systems that use different EHRs. To achieve this, we propose to refine and implement an
interoperable HIE platform that improves reliability of and access to necessary clinical information during IHT.
We will build on our prior work that identifies essential clinical information and data visualization for effective
HIE during IHT, and utilize user-centered design to rapidly identify, design, develop, refine, and implement
requirements from interprofessional users, including clinicians and personnel at transferring and accepting
hospitals. The HIE platform will use interoperable, data exchange standards and APIs to seamlessly integrate
with existing vendor EHRs within each use case. Our team will rigorously evaluate the impact of this
intervention on patient safety outcomes, including medical errors and adverse events, using interrupted time
series methodology, and our team will conduct robust mixed-methods evaluation on utilization, perceived
usability, and facilitators and barriers to implementation from interprofessional users who interact with the
platform. Finally, these data will be presented to steering committee members with expertise in care transitions
and dissemination strategy, and executive and health IT leadership from participating hospitals, to generate
input on best practices for further refinement and implementation to create a dissemination toolkit to share with
other similar institutions.

Public health relevance
PROJECT NARRATIVE Sub-optimal transfer of clinical information during inter-hospital transfer (IHT, the transfer of patients between acute care hospitals) is common and can lead to patient harm. To address this problem, we will use key stakeholder input to refine and implement an interoperable health information exchange platform that integrates with the electronic health record and improves the reliability of and access to necessary clinical information in three use cases involving transfer of patients between sending and receiving hospitals with varying levels of affiliation and health record integration. We will assess the effect of this intervention on frequency of medical errors, evaluate the use and usability of this platform from the perspective of those that interact with it, and use these results to develop a dissemination plan to spread implementation and use of this platform across other similar institutions.